TRANSCRIPTIONAL REGULATION OF THE VEGF GENE

Important insights into the regulation of angiogenesis will be gained by investigating the cellular and molecular pathways modulating vascular endothelial growth factor (VEGF) expression. My long-term goals are to characterize the distinctive roles of the transcription factors, hypoxia-inducible factor-1 (HIF-1) and endothelial PAS domain protein-1 (EPAS-1), in the regulation of the VEGF gene, and more broadly, on the control of angiogenesis. While HIF-1 is important in regulating angiogenesis by enhancing VEGF transcription in hypoxic states, I hypothesize that EPAS-1 plays an important role in angiogenesis under both normoxic and hypoxic conditions in a vascular cell-specific manner. Based on our preliminary data, we propose that carbon monoxide (CO), the product of heme oxygenase produced by vascular smooth muscle cells under hypoxia, plays a critical regulatory role in the function of EPAS-1. The specific aims of the proposed project are (i) to examine the regulation of EPAS-1 expression in vascular cells, (ii) to characterize the biologic function of EPAS-1 in vascular cells and (iii) to examine the molecular mechanisms by which CO regulates EPAS-1 function. The experimental design involves single-cell cultures in conjunction with transient transfection experiments to assess the role of EPAS-1 regulation of VEGF in vascular cells exposed to hypoxia. In addition, stably-transfected endothelial cells overexpressing heme oxygenase-1 will determine the effect of CO on EPAS-1 function. We will analyze specific post-translational mechanisms by which CO regulates EPAS-1 function, focusing on EPAS-1 phosphorylation and dimerization. These studies will increase our understanding of the molecular and cellular basis by which EPAS-1 regulates VEGF.